Hyaluronan in the limbal stem cell niche: from regulation of stem cell fate to translational applications

SUMMARY
Limbal epithelial stem cells (LESCs) produce transient amplifying cells (TACs) that move centripetally into
the cornea and differentiate into corneal epithelial cells (CECs). Thus, TACs represent a transition state
between LESCs and CECs. Studies have suggested some TACs retain stem cell-like characteristics. We
have recently shown that the LSCN is composed of a hyaluronan (HA)-rich matrix that is essential for
maintaining LESCs, and a loss of HA triggers LESC differentiation into CECs. Our unpublished data shows
that clusters of cells expressing an HA-rich matrix (HA-clusters) break away from the limbus and move into
the cornea containing LESC progenies with progenitor-like properties. Aim 1 will establish whether TACs
retaining progenitor-like characteristics are located within HA-clusters, and verify whether these TACs can
dedifferentiate into bona fide LESCs. The mechanism by which the HA-rich LSCN maintains LESCs
remains unknown. Our group recently characterized the composition of the HA-rich matrix within the LSCN,
identifying that heavy chains 2 and 5 (HC2 and 5) are transferred from inter-alpha-inhibitor onto HA by TSG-
6 to form specific HA/HC and HA/HC-TSG-6 complexes, and LESCs express CD44 and RHAMM, major cell
surface receptors for HA. Aim 2 will investigate whether HA/HC5(-TSG-6) complexes within the LSCN are
essential for maintaining LESCs, and whether the effects of HA on LESCs are mediated through CD44
and/or RHAMM cell surface receptors. Corneal injuries that decrease the overall number of LESCs may
lead to limbal stem cell deficiency (LSCD), a serious medical condition that leads to impaired vision and
severe pain, and, in more severe cases, complete loss of vision. Currently, treatment options for LSCD
include LESC transplantation or corneal transplantation, for which human donor corneas are required. A
major challenge for treating LSCD is the efficient preservation of LESCs in human donor corneas while
stored at eye banks. The composition of storage medium used by eye banks worldwide is determined by
the survival of corneal endothelial cells, without taking into consideration LESCs. Studies have reported that
limited LESCs are detected in human donor corneas after 4 days in storage, and we have found that there
is a significant loss of HA within the LSCN that occurs concomitantly with the loss of LESCs. Aim 3 will
investigate how the composition of the HA-matrix within the LSCN of human donor corneas changes over
time in storage and correlate the loss of HA with a loss of LESCs, and to improve the composition of
storage media to better support LESCs.
Clinical impact: Corneal diseases, including LSCD, are the third leading cause of blindness worldwide.
Corneal blindness is ultimately treated with corneal or LESC transplantation, for which human donor
corneas with viable LESCs are essential. This proposal will establish how the LSCN maintains LESCs,
unveiling fundamental biological mechanisms underlying LESC survival and LSCD pathogenesis.

Public health relevance
NARRATIVE Limbal epithleial stem cells (LESCs) reside in an HA-rich limbal stem cell niche (LSCN) and produce transient amplifying cells (TACs) that move into the cornea and differentiate into corneal epithelial cells (CECs). Aim 1 will investigate whether TACs retain this HA-rich niche as they move into the cornea and whether this HA maintains them in a progenitor-like state. Aim 2 will investigate whether HA/HC5(-TSG-6) complexes within the LSCN are essential for maintaining LESCs, and whether the effects of HA on LESCs are mediated through CD44 and/or RHAMM cell surface receptors, while Aim 3 will investigate how the composition of the HA-matrix within the LSCN of human donor corneas changes over time in storage causing a loss of LESCs, and to improve the composition of storage media to better support LESCs.